A Label-free Extracellular-vesicle Automated Purification System (LEAP System)

PROJECT SUMMARY / ABSTRACT
Extracellular vesicles (EVs) are small lipid bilayer particles secreted by most cell types, which encapsulates
biomolecules including lipids, proteins, and nucleic acids from cells of origin. Profiling of EV-derived biomarkers
provides a promising approach for diagnosis of various diseases. However, one of the primary challenges for
the research and application of EVs is a lack of a reliable method for efficient isolation of EVs and their
subpopulations from complex biofluids. Researchers in this field suffer from tedious workflow, long processing
time, high cost, and poor EV quality. To overcome the challenges, WellSIM proposes in this Phase II project,
which built upon the promising results generated from our Phase I project, to complete development of a Label-
free Extracellular-vesicle Automated Purification System (LEAP System) for isolation of total EVs or EV
subpopulations from a variety of biofluids in a non-invasive and cost-effective manner. Once developed, the
integrated LEAP System will offer excellent EV quality, throughput, and flexibility for EV isolation that can
outperform ultracentrifugation and other isolation techniques.

Public health relevance
PROJECT NARRATIVE One of the primary hindrances to the study and application of extracellular vesicles (EVs) is lack of a robust method for efficient isolation of EVs and their subtypes with high yield and purity. Our technique will facilitate fundamental studies of EVs by overcoming the existing challenges in EV isolation with distinct advantages. It will also speed up the translation of EV-associated biomarkers from laboratory to clinic by offering a high-throughput automation platform for EV population isolation and enrichment, allowing investigation of a large sample pool from clinical sources for exciting research and applications of EVs.